Parents’ Safety Nets, Child Protective Services Involvement, and Child Outcomes

Project Summary/Abstract
Child maltreatment is a serious problem in the U.S. and worldwide. An estimated 1 in 7 children are maltreated
each year, and most recent annual U.S. data suggest that over 618,000 child maltreatment cases were
substantiated. Approximately 30% of substantiated child and protectice services (CPS) cases lead to child
removal from the home and placement in foster care. Support networks, or safety nets, are a protective factor
associated with child abuse prevention. Research shows that, among vulnerable families in the general
population, strong safety nets, including informal and formal supports, are important because they protect
against risks and benefit parental health, parenting practices, and child wellbeing. Despite the documented
importance of safety nets for vulnerable families, we know much less about the safety nets of families involved
with CPS. Importantly, safety nets may work differently for CPS involved families (e.g., social isolation is a
characteristic of parents involved with CPS, parental lack of engagement in formal supports also is a
documented issue). Not understanding how informal and formal safety nets potentially complement or clash
with one another may contribute to less than desirable outcomes for families involved with CPS (e.g.,
inconsistent participation in services, child removal from the home). Given the potential protective power of
safety nets, not knowing how safety nets function specifically for families involved with the CPS is a significant
gap because we spent over $33.0 billion U.S. federal, state, local dollars on child protective services in the last
fiscal year. With a sample of families involved with the U.S. CPS, this project will identify: (a) parents’ informal
and formal supports (i.e., safety nets) over time; (b) how their safety nets are linked with child outcomes; and
(c) the extent to which their safety nets uniquely, additively, and interactively influence the longitudinal
outcomes of youth involved with CPS. This is important because parental engagement in intervention services
upon CPS involvement is key for positive family outcomes, yet we know very little about the combination of
informal and formal supports—and each have strengths and limitations. This project innovatively applies safety
net frameworks developed with low-income, vulnerable but non-CPS involved families, to families involved with
CPS. Results will move the field forward by filling an important research gap, and direct evidence-based shifts
in child welfare practices by identifying how safety nets function over time and with what results.

Public health relevance
Project Narrative Child maltreatment is a serious problem and an estimated 1 in 7 children are maltreated each year. Strong support networks, or safety nets, are a protective factor associated with child abuse prevention, yet we know little about the safety nets of families involved with child protective services. This project has the potential to inform child welfare policy and practice nationwide by determining the effects of safety nets on child permanency and mental health outcomes over time.